Differentiation and function of transitional monocytes in cancer metastasis to the lung

Project Summary/Abstract
Cancer metastasis occurs when cancer cells spread to distal organs from their site of origin, and it is the
leading cause of death in patients with solid cancers. When cancer spreads to the lung, various types of innate
immune cells either help or inhibit this colonization process. Monocytes are one of the earliest cell types to
flood the lung during the beginning of metastasis. These monocytes eventually become tumor-supporting
metastasis-associated macrophages (MAMs), and many studies in the field have reported that monocytes and
MAMs actively aid metastatic cancer to infiltrate the lung and take residence there. My project aims to
understand how monocytes differentiate into MAMs; in particular, what signals and factors are critical for this
transition to occur in the lung. Furthermore, from my preliminary data, I have identified a time window during
which monocytes have undergone clear phenotypic changes but have not yet fully developed into MAMs.
Interestingly, this transition period also coincides with the anti-tumor activity of other immune cell types, such
as natural killer (NK) cells. Therefore, I aim to study the interactions between pro-tumoral monocytes and anti-
tumoral NK cells during the first several hours of cancer metastasis to the lung. By understanding how the
mechanisms that underlie these interactions help to increase the odds of metastatic establishment in the lung, I
will be able to contribute valuable insights towards novel therapeutic efforts to prevent metastasis.

Public health relevance
Project Narrative During the early phase of cancer metastasis to the lung, monocytes are recruited to the lung and differentiate into metastasis-associated macrophages (MAMs). Both monocytes and their progeny MAMs are known to play tumor-supporting roles and exacerbate metastasis in the lung. The goals of this proposal are to identify the signals and factors that influence monocyte differentiation and to define the function of monocytes during their transition into MAMs.